Deciphering and predicting ecologically sensitive gut microbiome contributions to human metabolic health

ABSTRACT
Metabolic health depends on acquiring an appropriate amount of energy and allocating it efficiently across tissues.
The human gut microbiome modulates energy acquisition and allocation and exhibits high sensitivity to modifiable
lifestyle factors such as diet, exercise, and social contact, resulting in gut microbiome contributions to metabolic
health that differ across individuals and within individuals over time. Ecological plasticity of the gut microbiome is
a double-edged sword: it may increase disease risk if the microbiome departs from profiles to which the human
body has adapted, but it may also confer protection by affording humans some capacity to adapt rapidly to
changing ecological conditions. However, health outcomes of lifestyle-associated alterations in the gut
microbiome remain untested. This situation complicates the interpretation of human gut microbiome variation,
hinders efforts to develop equitable microbiome-targeted therapeutics, and obscures our view of features
characterizing a ‘healthy’ human microbiome. In the coming five years, we will perform experiment-based,
causally informative research toward three synergistic themes that elucidate when, why, and how lifestyle affects
gut microbiome contributions to metabolic health. In Theme 1, we interrogate how ecological factors such as
dietary digestibility, caloric intake, and exercise shape gut microbiome contributions to host metabolic health and
the conditions favoring inflection points between beneficial and detrimental contributions. In Theme 2, we evaluate
how ecological context shapes the metabolic health consequences of host-microbiome interactions and whether
it may benefit health to restore putatively beneficial taxa depleted in industrialized or non-industrialized gut
microbiomes. In Theme 3, we investigate how social microbial transmission may mediate metabolic disease risk
and resilience, testing the idea that non-communicable conditions have a communicable component by virtue of
the social exchange of risk-associated microbes. To address Themes 1 and 2, we will exploit natural variation in
human microbiomes and controlled diet and exercise interventions in mice to foster conditioned gut microbiomes
that can then be transplanted into germ-free animals to study the causal health impacts of a given microbiome
profile. To address Theme 3, we will examine the transmissibility of microbes between focal individuals with
metabolic disease and their social partners, varying focal and partner social networks to evaluate the risk
landscape of social transmission in relation to social position and connectivity. Work toward Themes 1-3 will be
enhanced by three overarching principles guiding our work: (1) consideration of both bacterial and non-bacterial
constituents of the gut microbiome, (2) rigorous host and microbiome phenotyping enabling the elucidation of
underlying mechanisms, and (3) development of machine learning models that identify metagenomic and
metabolomic features predicting gut microbiome contributions to metabolic health. Collectively, our proposed
research will enhance our understanding of human energy metabolism and help lay the groundwork for future
health-directed manipulation of the gut microbiome.

Public health relevance
PROJECT NARRATIVE The human gut microbiome contributes critically to metabolism and varies with modifiable lifestyle factors such as diet, exercise, and social contact, but we currently know very little about how ecological plasticity in the gut microbiome causally affects metabolic health. We propose to close this gap by leveraging natural variation among human gut microbiomes and controlled experiments in conventional and germ-free mice to elucidate the conditions under which gut microbiome plasticity exerts beneficial or detrimental effects, decipher the mechanisms underlying these effects, and predict microbiome metagenomic and metabolomic features promoting metabolic health. Collectively, this work will enhance our understanding of human energy metabolism, enable us to more responsibly interpret microbiome variation observed across humans, and reveal the contexts and levers favoring effective gut microbiome modification in the service of health.